Creation of the Human Cancer Metabolome Atlas

Project Summary/Abstract
Metabolic reprogramming is a hallmark of cancer, prompting molecular mechanisms to promote tumor survival,
growth, and resistance to treatment. Therapeutic targeting of tumor metabolism therefore is believed to be a
promising avenue of cancer treatment. To further the development of metabolism-targeted cancer therapy,
more information is needed concerning the heterogeneity of tumor metabolism and how tumor type, stage, and
other tumor/patient characteristics determine the metabotype of tumors. Although publicly available resources
exist for genomics and proteomics data, such as The Cancer Genome Atlas (TCGA) and the Human Proteome
Atlas (HPA), no such database exists for the cancer metabolome. Resources like TCGA and HPA have
become cornerstones of cancer research, making the lack of a cancer metabolome resource a glaring
omission, particularly since metabolomics is considered to be the omics closest to phenotype. We propose to
create the Human Cancer Metabolome Atlas (HCMA) by collecting metabolomics data on numerous patient-
derived tumors and making an open-access resource to the cancer community to better understand the role of
metabolism in cancers. In Aim 1,we will analyze a large-scale collection (>2000) patient-derived xenografts
(PDXs) using mass spectrometry-based metabolomics. We will obtain these PDXs from NCI’s patient derived
model repository (PDMR), Charles River Laboratory, and Crown Bioscience. Each PDX model has already
been characterized by RNA-sequencing, whole exome sequencing, and comes with a wealth of patient
information/metadata. In Aim 2, we will evaluate how metabotypes of PDXs vary based on gene expression
patterns, presence of metastatic disease, and survival outcomes. Using a combination of univariate,
multivariate, and pathway analyses, we will uncover key roles of cancer metabolism in these processes and
which aspects of cancer metabolism contribute to heterogeneity across patients. Finally, in Aim 3 we will create
a public resource for the HCMA using the National Metabolomics Data Repository (NMDR, also known as
Metabolomics Workbench). Raw and processed metabolomics data will be uploaded to this resource along
with associated patient metadata and existing genetic data to facilitate data mining and discovery efforts to be
performed by outside investigators. Existing data analysis modules of the NMDR including univariate analysis,
multivariate analysis, pathway analysis, and metabolite class analysis will be integrated with the HCMA to
make the metabolomics data accessible and easily analyzable by other investigators. This resource will
continually be built upon in future proposals to expand the HCMA and provide a powerful resource for new
discoveries in cancer biology and therapeutics.

Public health relevance
Project Narrative The metabolic heterogeneity of tumors is poorly understood, and more information is needed to uncover the metabolic features of tumors related to aggressiveness, tissue type, and patient demographics. This proposal aims to conduct a large-scale, pan-cancer metabolomics analysis to generate a publicly available resource, called the Human Cancer Metabolome Atlas, to provide a platform for all cancer researchers to study the landscape of tumor metabolism. Cancer metabolism has gained tremendous traction as a source of potential therapeutic targets, and this resource will not only help to better identify those targets, but it will also identify subpopulations of individuals who would best respond to these approaches.